MCAFDO Annual Education Conference

Project Summary
The long-term objective of the Mid-Continental Association of Food and Drug Officials (MCAFDO) is to
continue to hold an annual regional meeting encompassing members from the states of Arkansas, Iowa,
Kansas, Missouri, Nebraska, Oklahoma, and Texas.
Specific Aims:
• Improve communication and cooperation within the local, state, and federal programs
• Promote the development and enforcement of uniform food, drug, and consumer protection
laws
• Recruit new members and increase association activities each year
• Work with AFDO to draft resolutions, policies, and model legislation affecting the public and the
industry
• Develop support from AFDO for regional objectives to provide an effective voice on the national
level for MCAFDO members
• Fosters partnerships between industry and regulators within the region
This grant would greatly assist MCAFDO in continuing to support our organization’s objective (stated
above) as well as support bring in the subject matters experts needed to thoroughly educate and discus
topics important to our stakeholders.

Public health relevance
Project Narrative With funds and support from this grant, Mid-Continental Association of Food and Drug Officials (MCAFDO) members will continue to gain and share information at our annual conference. Topics discussed at this event can be used in a number of health and food safety programs throughout the Midwest, increasing the success of consumer safety programs and initiatives throughout Arkansas, Iowa, Kansas, Missouri, Nebraska, Oklahoma, and Texas.